DEFINING THE FUNCTION OF PROTEASOMAL DEUBIQUITINASES

Project Summary
The 26S proteasome is a massive, intricately regulated ATP-dependent protease that is responsible for the
degradation of most cellular proteins. Failure of the proteasome to precisely regulate protein levels is a
hallmark of many cancers and neurodegenerative diseases. Targeting proteins to the proteasome requires
covalent modification with a polymeric (Ub) chain. Thus, it is perplexing that the proteasome actually houses
enzymes (deubiquitinases/DUBs) responsible for removing Ub chains. While it has become clear that the
intrinsic DUB, RPN11, promotes degrades by preventing premature deubiquitination of proteins not yet
engaged with the proteasome, the roles of other proteasomal DUBs, e.g., UCH37/UCHL5, are poorly
understood. In preliminary studies, we discovered that proteasome-bound UCH37 acts as a chain editor by
removing branch points. This application proposes to elucidate how UCH37 selects branched Ub chains for
editing, how this activity is integrated into the entire process of proteasomal degradation, and how it impacts
the turnover of cellular proteins. In Aim 1, we will investigate the role of UCH37-mediated chain debranching
during proteasomal degradation using distinct, purified human proteasome complexes and fluorescent,
polyubiquitinated substrates. In Aim 2, we propose to identify cellular targets of proteasome-bound UCH37
using an innovative combination of quantitative proteomics, in-cell proximity labeling, and Ub middle-down
mass spectrometry. In Aim 3, we focus on understanding the molecular basis of UCH37's specificity toward
branched chains. Finally, in Aim 4, we will develop novel cyclic peptide inhibitors of UCH37 to facilitate efforts
to dissect its function in any biological paradigm. The knowledge gained from this research will shed light on
fundamental aspects of the ubiquitin proteasome system and pave the way for the development of new
therapeutics that regulate proteasome function.

Public health relevance
Project Narrative This proposal aims to understand how a proteasome-associated deubiquitinase works to regulate protein degradation. Our recent discovery that proteasome-bound ubiquitin chains are edited by removing branch points suggests chain debranching plays an important role in the degradation process, and in this applica- tion we will test this hypothesis. The translation of our fundamental insights into small molecule modulators is especially important as many disease-related pathways are regulated by aberrant proteasome function.